The emergence of abstract structure knowledge across learning and sleep

In any given cognitive domain, representations of individual elements are not independent but are organized by
means of structured relations. Representations of this underlying structure are powerful because they can allow
generalization and inference in novel environments. In the semantic domain, structure captures associations
between different semantic features or concepts (e.g., green, wings, can fly) and is known to influence the
development and deterioration of semantic knowledge. We recently found that humans find it easier to learn
novel categories that contain clusters of reliably co-occurring features, revealing an influence of structure on
novel category formation. However, a critical unknown is whether learned representations of structure are closely
tied to category-specific elements, or whether they become abstract to some extent, transformed away from the
experienced features. Further, if abstract structural representations do emerge, prior work provides intriguing
hints that they may require offline consolidation during awake rest or sleep. We have developed a paradigm in
which carefully designed graph structures govern the pattern of feature co-occurrences within individual
categories. Here we implement a "structure transfer'' extension of this paradigm in order to determine whether
learning one structured category facilitates learning of a second identically structured category defined by a new
set of features. This facilitation would provide evidence that structure representations are abstract to some
degree. Aim 1 will use these methods to evaluate whether abstract structural representations emerge
immediately during learning. Aim 2 will determine whether these representations persist, or emerge, over a delay,
and whether sleep-based consolidation in particular is needed. The role of replay of recent experience during
sleep will be evaluated using electroencephalography (EEG) paired with closed-loop targeted memory
reactivation (TMR), a technique that enables causal influence over the consolidation of recently learned
information in humans. This work will inform and constrain theories of semantic learning as well as theories of
structure learning and representation more broadly.

Public health relevance
Our understanding of the world is often tied to the particular experiences we have had, but can sometimes result in noticing an underlying rule that can be applied to new situations. This proposal seeks to determine the extent to which representations of the underlying structure of categories of objects emerge during initial learning versus over a period of subsequent rest or sleep. The work could have implications for understanding the cognitive deficits in mental health disorders such as depression and schizophrenia, which have profound disturbances to learning and sleep.